Project 3: Care Integration for Patients with Cancer Receiving Post-Acute Care and Hospice

PROJECT SUMMARY/ABSTRACT: Project 3 -
This Project focuses on care integration for patients with cancer who are treated in post-acute (skilled nursing facilities, inpatient rehabilitation facilities, and home health) and hospice settings. Care for patients with cancer at the end-of-life is often fragmented and not patient-centered. Less is known about the coordination and quality of post-acute care for patients undergoing complex cancer surgeries and hospitalizations for disease- and treatment-related complications. There has been substantial consolidation in post-acute care and hospice settings, including a marked increase in the prevalence of for-profit chains. Structural integration across sectors (e.g., with systems/hospitals) could increase other forms of integration, such as: functional (e.g., policies and protocols for coordination of care across settings), normative (e.g., common culture), interpersonal (e.g., collaboration and teamwork within and across organizations), and clinical process integration (e.g., activities integrating services across settings). Alternatively, such structural integration could increase incentives for referrals to lower-quality facilities, service or staffing reductions, or employment of less skilled clinical staff. Working with Projects 1, 2, and 4 and the Cores, the team will conduct case studies and interviews of clinicians within health systems and their hospitals and practices as well as clinicians and staff in post-acute care and hospice settings to evaluate how structural features (e.g. co-location, referral patterns, geographic reach) relate to these other non-structural forms of integration. The team will survey medical and nursing directors, clinicians, and staff from a random sample of post-acute and hospice facilities that do not have ownership arrangements with health systems to measure non-structural forms of integration outside of health systems. The team will use Medicare administrative data to describe key outcomes, such as utilization (e.g. readmissions), spending, and high quality care (e.g., post-operative complications, patient/family experiences), and to examine associations between integration types and outcomes overall and for patient subgroups such as low-income patients and patients living in rural areas. The aims are: Aim 1: Adapt an existing framework to describe key forms of integration (i.e., structural, functional, normative, interpersonal, and process) for the care of oncology patients in post-acute care and hospice settings and identify mechanisms through which forms of care integration may produce improved care and outcomes for patients using post-acute and hospice care. Aim 2: Measure care integration in post-acute care and hospice settings and assess relationships among different forms of care integration. Determine how these relationships vary by agency and market factors. Aim 3: Assess the association of integration in post-acute care and hospice care settings with utilization, spending, and high-quality care for patients with cancer, and assess mechanisms through which integration improves or worsens care overall and for patient subgroups such as low-income patients and patients living in rural area.

Public health relevance
PROJECT NARRATIVE: Project 3 – Care Integration for Patients with Cancer Receiving Post-Acute Care and Hospice There has been substantial consolidation in post-acute care (i.e. skilled nursing facilities in patient rehabilitation facilities and home health) and hospice settings but the impact of such structural integration on patients with cancer remains unclear. This research together with the other Projects will seek to characterize how structural integration relates (if at all) to other forms of integration that might have more direct benefits for patient care. By studying care integration for patients with cancer treated in post-acute care and hospice settings the proposed research will help clinicians cancer care leaders and policymakers to identify and facilitate more meaningful care integration that leads to higher quality care for patients with cancer.